Novel treatments for neuropsychiatric symptoms in Alzheimers Disease (AD): targeting inflammatory injury using three translational anti-inflammatory strategies in a new AD model.

Alzheimer’s disease (AD) affects 1 in 8 Americans, and is the sixth leading cause of death in the United States.
Nearly a quarter of a million of those living with AD are Veterans, and recent studies have shown that Veterans
have a 60% increased risk of developing AD. Behavioral changes, such as agitation and aggression, confusion,
and dramatic personality changes, termed neuropsychiatric symptoms (NPS) are highly prevalent in AD patients,
and are extremely challenging for caregivers, placing significant emotional and financial burdens on those caring
for patients with AD, yet current pharmacological treatments for NPS, such as antipsychotics, sedative/hypnotics,
anxiolytics, and antidepressants, often have significant adverse effects that outweigh the benefits of these
treatments. Thus, it is critical to develop better therapeutic approaches to NPS in AD patients. In the general
psychiatric literature, there is an emerging idea that inflammation may be a critical contributor to the etiology of
psychiatric conditions including mood disorder, major depression, post-traumatic stress disorder (PTSD), and
even schizophrenia. How inflammatory processes contribute to neuropsychiatric symptoms in AD has not yet
been studied. Neuropsychiatric manifestations in AD patients occur in the context of a progressive
neurodegenerative disease – the characteristic of AD - which produces substantial inflammation, itself, so we
believe it is critical to understand the role of inflammation in NPS specifically in the context of AD, the ultimate
goal of this application.
This application is based on the emerging idea that brain inflammation may contribute to psychiatric
conditions including depression, post-traumatic stress disorder (PTSD), and even schizophrenia. We propose
the hypothesis that treating neuroinflammation in AD patients will prevent or decrease neuropsychiatric
symptoms such as agitation, aggression, and apathy, with the potential of finding alternative and better
treatments for Veterans with these difficult-to-treat and often devastating behavioral symptoms of AD.
The premise for this grant is based on the literature, our published data, and new preliminary data, which show
that anti-inflammatory treatment treatments directed at interleukin-6 (IL-6) signaling, specifically, will be effective
in attenuating NPS in relevant models. Aim 1 will ask whether evidence of inflammation predicts increased risk
of NPS in a new mouse model of AD (the hAPP knockin mice recently developed at the Riken Institute) - mice
known to exhibit progressive brain inflammation - and will characterize how aged AD mice perform on behavioral
tasks relevant to human NPS. Markers of inflammation to be correlated with behavior will include serum C-
reactive protein and IL-6, which have been strongly associated with many psychiatric disease states. In addition,
neuroinflammation will be assessed by quantifying the number of activated astrocytes (GFAP) and microglia
(Iba1) using confocal fluorescence imaging of brain slices at three ages: 5, 12, and 18 months. Males and
females will be studied. Aim 2 will test the hypothesis that three anti-inflammatory strategies targeting IL-6 and
downstream signaling will reduce NPS behaviors in these same mice. Treatments will include: siltuximab
(Sylvant), a clinically approved anti-IL-6 immunotherapy; Apocynin, a NADPH oxidase inhibitor; and
Dismutazyme, a small molecule catalytic superoxide dismutase mimetic, shown to be effective in mice and non-
human primates. The goal will be to determine whether these anti-inflammatory treatments prevent or reduce
NPS in AD. Ultimately, if treatments which reduce inflammation in the brain prevent or decrease NPS in AD
patients, this could support development of alternative or adjunct treatments to conventional drugs being used,
thus improving the quality of life and decreasing the burden of NPS in patients living with AD. Finally, results
from this study may suggest that biomarkers of inflammation could be used as predictors of NPS risk, thus
improving risk stratification for clinical studies on NPS in AD.

Public health relevance
Alzheimer’s Disease (AD) affects over 5 million Americans, and a quarter of a million Veterans. A majority of AD patients will exhibit neuropsychiatric symptoms (NPS) including aggressive behavior, personality changes, and depression. These behaviors are extremely challenging for caregivers and families, but no good treatments exist for NPS in most patients. Recent studies have suggested a role for inflammation in many psychiatric disorders, but almost nothing is known about how inflammation may influence NPS in AD patients. This proposal will test the idea that treatments which reduce neuroinflammation will be highly effective in preventing NPS. The project will test 3 anti-inflammatory strategies for their effects in preventing or decreasing NPS in a model of AD. If the project is successful, one or more of these treatments could be moved quickly into clinical trials. The ultimate goal of this project is to find better treatments for patients, including Veterans, who develop these difficult-to-treat and often devastating behavioral symptoms associated with AD.